Dual infrared visible confocal microscopy for imaging inter-cellular communication

Intercellular signaling is central to understanding the molecular basis of biological processes ranging from
nutrient uptake, response to stimulus in plants and animals, disease inception, neurobiology and cognition,
immune responses, and cellular communication. Our MIRA R35 centers on developing nm-scale near-infrared
biosensors that can report on extracellular chemical communication, through which we have already developed
numerous near-infrared nanosensors to image extracellular chemical analytes in the first 3 years of our award.
In late 2019, new commercial camera hardware became available that – for the first time – enables concurrent
imaging of visible and near-infrared wavelengths with the same detector. We are requesting an equipment
supplement to enable building a multiphoton microscope to enable concurrent near-infrared fluorescence
imaging of cellular efflux with our nanosensors together with a new capability in imaging cellular transcriptional
and morphological changes with visible fluorescence imaging that accompany cytokine signaling. In the first 3
years of our award, we have developed numerous near-infrared nanosensors for extracellular chemical analytes
including dopamine, neuropeptide oxytocin, cytokine VEGF, glucose, and hydrogen peroxide. The purpose of
our equipment supplement request is to take advantage of new fluorescence imaging technology, specifically a
visible and near-infrared sensitive camera, that will enable us to image both intracellular and extracellular
changes that underlie cell signaling in real-time. Direct cellular imaging of secreted cytokines (prior R35 goal)
together with single-cell changes in transcription and morphology (new R35 goal with technology supplement)
will provide a new paradigm on how cytokine secretion profiles from single or few individual cells are stimulated
by chemokines and cytokines, which forms the basis of the cytokine secretion profiles currently used in
biomarker-based diagnostics.
Landry ABSTRACT AB-1

Public health relevance
Cell signaling with small molecules, peptides, and proteins are central to the development of auto-immune disorders, infections, cancers, and central nervous system disorders. We will build a dual multiphoton swept- field confocal microscope for imaging in both the visible and near-infrared to enable visualization of cytokines from singular cells and in real-time, simultaneous to cell growth and gene expression. This comprehensive approach to imaging how cell structure and gene expression changes together with a cell’s secretion of signaling molecules will illuminate cellular communication for development of more precise diagnostic tools and therapies. Landry PROJECT NARRATIVE PN-1